NIDCD Core for Clinical Research and Care

The NIDCD Core for Clinical Research and Care supports the following NIDCD projects: 1 Z01-DC-000016 NF-kappaB in the molecular pathogenesis and therapy of Neoplasms Affecting Human Communication 1 ZIA DC000039 Identification of Genes Causing Syndromic And Nonsyndromic Hearing Impairment 1 ZIA DC000046 Genetic Studies of Human Communications Disorders 1 ZIA DC000060 Molecular Analysis Of Human Hereditary Deafness 1 ZIA DC000064 Clinical Analysis Of Disorders Of Hearing And Balance 1 ZIA-DC-000073 Signal and Transcription Factor Network Interactions in Head and Neck Cancer 1 ZIA-DC-000074 Genomics and Proteomics of Head and Neck Cancer 1 ZIA-DC-000082 Neurotology Program 1 ZIA-DC-000087 Characterization & Enhancement of Anti-tumor Immune Responses in Head & Neck Cancer 1-ZIA-DC-000088 Cellular and Molecular Pathogenesis of Hearing Restoration in Adullt Inner Ear 1-ZIA-DC-000090 Mechanisms and Optimal Combination of Cisplatin Chemotherapy for Head and Neck Cancer The NIDCD and collaborative protocols supported by the core include: OH93-DC-0016 - Nonsyndromic Hereditary Hearing Impairment Gene Mapping: India / Pakistan Protocol 97-DC-0180 - Genetic Analysis of Human Hereditary Hearing Impairment 01-DC-0228 - Clinical and Molecular Analysis of Hearing Impairment with Enlarged Vestibular Aqueducts 01-DC-0229- Genetic Analysis of Hereditary Disorders of Hearing and Balance 17-DC-0138 - Cisplatin and statins in ototoxcity 18-DC-0051 - NIDCD Biospecimens protocol 20-DC-0047 Natural History and Genome Editing in Dominant Hearing Loss 21-DC-0002 Phase III Interventional Study using Atorvastatin to Reduce Cisplatin-Induced Hearing Loss 21-C-0009 A Natural History Study of Children and Adults With Olfactory Neuroblastoma 000077 Clinical Data and Specimens in head and neck disorders 000141 Hearing Instability Phenotyping 15-D-0129 Dose-Escalation Study Evaluating the Safety of a Single Administration of an Adeno-Associated Virus Vector Encoding Human Aquaporin-1 in Irradiation-Induced Parotid Salivary Hypofunction 19-C-0041 Birinapant and Intensity Modulated Re-Irradiation Therapy (IMRRT) for Locoregionally Recurrent Head and Neck Squamous Cell Carcinoma 19-C-0002 A Phase II Study of M7824 in Subjects with Recurrent Respiratory Papillomatosis 20-C-0024 Anti-PD-L1/TGF-beta Trap (M7824) Alone and in Combination with TriAd Vaccine and N-803 for Resectable Head and Neck Squamous Cell Carcinoma Not Associated with Human Papillomavirus Infection 20-C-0155 Phase I/II Trial Investigating the Safety, Tolerability, Pharmacokinetic , Immune and Clinical Activity of SX-682 in Combination with M7824 With CV301 TRICOM in Advanced Solid Tumors 20-C-0104 Phase I/II Trial of HPV Vaccine PRGN-2009 Alone or in Combination with Anti-PD-L1/TGF-Beta Trap (M7824) in Subjects with HPV Positive Cancers 21-C-0013 A Phase I Study of Adjuvant PRGN-2012 in Adult Patients with Recurrent Respiratory Papillomatosis The NIDCD Core for Clinical Research and Care supports over 3,000 outpatient clinic evaluations per year. Core otolaryngologists perform 50-100 major surgical cases annually. Staff mentor medical students during senior clinical clerkships. The Otolaryngologist Surgeon Scientist Career Development Program is coordinated through the OCD.